CORE A - Administration

Summary/Abstract
The Administrative Core functions as a central resource to maximize interactions through efficient coordination
of the four individual Projects and two Scientific Cores so that the Program as a whole can achieve its goals. Dr.
Baker, the Principal Investigator of the P01, serves as the director of the Administrative Core, and she will have
primary responsibility for the overall conduct of the Program Project. The Administrative Core will continue to
organize regular Program meetings of the Project and Core Leaders to facilitate communication, maximize
collaborative interactions among the individual members of the Program, and to provide a forum to share and
monitor progress of the group. The Core will also organize regular work-in-progress seminars given by lab staff
and Leaders from each Project and Scientific Core, to report progress, foster collaboration and provide
information about conceptual and technical advances. Dr. Gilbertson participates in Program meetings from
Cambridge University through videoconferencing. The Administrative Core is responsible for general
administrative oversight of all of the Projects and Cores, and budgetary management of the program.
Centralization of these activities promotes efficient management of program resources, and will significantly
facilitate communication between Project and Core Leaders. The Administrative Core will provide centralized
administrative assistant support, and will assist with scheduling of monthly program meetings of Project and
Core Leaders, regular discussions and interactions with the Internal Advisory Board, External Advisory Board
visits, and preparing quarterly and yearly financial reports and yearly progress reports. Dr. Baker will ensure
that the research performed through this Program Project is in compliance with NIH and Institutional
requirements.

Public health relevance
Core Narrative The Administrative Core functions as a central resource to maximize interactions through efficient coordination of the individual Projects and Core Laboratories so that the Program as a whole can achieve its goals. The Core facilitates interactions between Program members, monitors progress and core usage, and is responsible for administrative oversight and budget management.